Biomarkers of Kaposi sarcoma recrudescence in Zambia

ABSTRACT
Kaposi's sarcoma (KS) remains a highly prevalent malignancy in sub-Saharan Africa. Antiretroviral
therapy (ART) and associated immune reconstitution has been correlated with a dramatic decline in
the prevalence of KS in the US HIV infected population, but the impact of ART on KS in sub-Saharan
Africa is less clear. In Zambia, even with the scale up of ART, KS remains the second most common
cancer among adult men. For women, it is the third most common. Furthermore, treatment with
chemotherapy plus ART is associated with recurrence rates of up to 50 percent in those that have a
complete response. The overall objective of this application is to identify markers of epidemic KS
recurrence and/or sustained remission in individuals that have an initial complete regression of
lesions upon chemotherapy. We hypothesize that individuals with complete regression of all the
lesions after chemotherapy will have differences in immunological and viral factors that have
prognostic value for predicting KS re-development and/or sustained remission. We will test our
hypothesis by longitudinally characterizing innate, humoral, and cellular immune responses against
KSHV and comparing individuals that experience recurrence to those who do not. The identification of
these biomarkers of outcome after remission will enable the selection of patients that require a longer
follow up period, those that require maintenance therapy, and those that require second line
chemotherapy. From our proposed activities, we will improve the long-term outcomes of HIV+
individuals that have had KS before and hence at high risk of recurrence. This will ultimately inform
efforts to better understand KS pathogenesis and develop novel interventional strategies.

Public health relevance
PROJECT NARRATIVE This study is the first to prospectively investigate biomarkers of Kaposi's Sarcoma recrudescence or stable remission in a cohort of Zambian epidemic KS patients on ART that initially achieved remission after chemotherapy.